MANAGEMENT OF UNHEALTHY OPIOID AND POLYSUBSTANCE USE AMONG PATIENTS IN PRIMARY CARE SETTINGS. FY22. POP 9/15/22 - 9/14/27.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.